Dissecting the neural mechanisms of hedonic hunger and its effects on aging

Project Abstract
Healthy aging may be a case of mind over matter. Experiments in systems ranging from worms to mice have
established that neural states, which humans often associate with the feelings and motivations behind our
behaviors, may be as influential as physical experiences in promoting a long and healthy life. One major
motivational drive for animals is hunger, which promotes feeding. Feeding can be generated by the
physiological need to consume nutrients as well as the hedonic properties of food. While brain circuits and
mechanisms that regulate feeding have been described, it is unclear how they contribute to the generation of
motive forces that drive feeding, and ultimately impact aging. Based on visually identified and quantified
behaviors exhibited by hungry flies, we have found that flies exhibit distinct and measurable hunger drives that
can be homeostatic (i.e., need-based) or hedonic (i.e., pleasure-based). These can be distinguished, at least in
part, using sophisticated feeding behavior metrics that have shown homeostatic feeding is best represented by
the number of feeding events on a protein rich food, while hedonic feeding is characterized by the duration of
feeding events on a highly palatable food. We have discovered specific regions of the fly brain that influence
feeding duration on palatable food but not the number of protein food events, suggesting that they are involved
specifically in hedonic feeding. While the direct manipulation of homeostatic hunger has been shown to extend
lifespan, preliminary data from our laboratory indicate that hedonic drive shortens fly lifespan. To understand
how hedonic feeding is generated by the brain and manipulate this hedonic perception, we will determine how
the identified hedonic neural circuitry encodes a hedonic hunger state in Aim 1. For Aim 2, we will identify how
different levels of hedonic perception influences aging in Drosophila. The proposed study will provide key
insight into how the brain weighs environmental cues to drive hedonic feeding behavior and how hedonic
feeding impacts lifespan in various environmental contexts. Additionally, we will manipulate these cues to
determine the cellular mechanisms through which feeding neural states can affect healthy aging.

Public health relevance
Project Narrative Experiments in systems ranging from worms to mice have established that neural states, such as hunger drive, may be as influential as physical experiences, such as feeding, in promoting a long and healthy life. The goal of this application is to identify and dissect the neural circuitry through which hedonic hunger states, which promote pleasure-based feeding, are encoded in the brain and to determine the signaling pathways through which they influence aging in Drosophila. This project will highlight potential avenues of how neural states can affect healthy aging.